Discovery of Molecular Probes and Therapeutic Leads

ABSTRACT
An administrative supplement is requested to purchase an Advion Expression and Plate
Express CMS system to support P20 GM104316: Discovery of Chemical Probes and
Therapeutic Leads. The goal of this COBRE is to continue our efforts to develop
molecular approaches for probing biology, to discover and apply new chemical biology
tools for the study of biological pathways associated with disease, and to develop
computational approaches for understanding small molecule interactions with complex
macromolecular targets. The goal of this administrative supplement is to request funds
for the purchase of an Advion Expression and Plate Express CMS system. The
proposed instrument will be used by over 60 researchers and will be a critical tool for
the COBRE custom synthesis lab which has already served over 20 groups on the UD
campus. The Advion is a compact, single quadrupole ESI/APCI mass spectrometer (up
to 2000 m/z) that offers unique capability in terms of sample introduction. The
instrument will support major new capabilities for the COBRE community: (1) real-time
reaction monitoring using the Plate Express enabling users to directly analyze TLC
spots on a developed TLC plate. (2) Direct fraction checking of chromatography
fractions using the ASAP probe will add MS-capability to the traditional flash, automated
flash, and HPLC systems that are routinely used by more than 60 users.

Public health relevance
Project Narrative This center of Biomedical Research Excellence is a multidisciplinary center that using synthesis, chemical biology and computation to develop molecular approaches for understanding and treating human disease, with a focus on infectious diseases and cancer.